SOLVATION AND ION STABILIZATION OF THREE STRANDED NUCLEIC ACID STRUCTURES

There are three aspects to this project:1.Analysis of new X-ray structures of the ribosomal 23S RNA fragments bound to protein L11 revealed formation of the mini-triple helices predicted by us in 1994 (the so called R-form, or recombination triplex). These mini-triplexes contain iso-geometric GC:G and CG:C triads of bases. Covariation analysis of the 23S RNA sequences indicates that mutations in the latter triad are consistent with formation of one more homologous triad, UA:U, which so far has not been observed directly.2. Radioprobing studies of the RNA polymerase-DNA-RNA complex revealed new details of the spatial arrangement of the RNA strand with respect to the DNA transcription [unreadable]bubble[unreadable] (in collaboration with Dr. R. Neumann, Clinical Center). Among the novel features of the complex is the three- stranded complex DNA-DNA-RNA at the [unreadable]upstream[unreadable] end of the bubble. The functional role of this structure may be related to stabilization of the transcription elongation complex.3. A new project has been initiated to study the R-form triplex in solution. The oligonucleotides with the non-nucleotide linkers were designed based on our calculations, and synthesized -- this was done to facilitate formation of the intranucleotide triplexes and to avoid aggregation. The R- triplex has geometry different from that of the better known H- triplexes. In particular, all three grooves in the R-form have comparable widths. Therefore, it is important to select specific cations that would be most favorable for this unusual structure. The optimal conditions for formation of R-triplexes in solution were found calorimetrically (in collaboration with Dr. A. Shchyolkina, Inst. Mol. Biol., Moscow, Russia). As expected, LiCl in high concentration is the most effective stabilizer of the R-form (Li has a low specificity and a large hydration shell). These conditions will be used in the NMR measurements (in collaboration with Dr. A. Gronenborn, NIDDK).Z01 BC 10046-04 - DNA folding, Gene regulation, molecular interactions, RNA folding, synthesis chemistry, transcriptional control,